TEMPORAL RESOLUTION OF VISUAL PERCEPTION

The first stages of human visual processing proceed very rapidly, representing the retinal input with high temporal resolution. However, it appears that the visual system extracts only a very few aspects of the retinal input before subsequent slow filtering. The proposed experiments are designed to determine exactly what these privileged, high-speed aspects are. In addition, the transition or transitions from fast to slow processing will be functionally localized with respect to a wide variety of visual processes. Finally, we will test the hypothesis that a common filter is responsible for the low resolution of the slow visual processes.